BioRaptr Replacement Dispensers to Support High Throughput Screening

PROJECT SUMMARY:
The Herbert Wertheim UF Scripps Institute for Biomedical Innovation & Technology (Formerly: Scripps
Research Institute-Florida) is requesting funds for the purchase of replacement BioRaptr dispensers to
support its operations in High Throughput Screening at its UF Scripps HTS center for drug discovery.
These plate dispensers are direct replacements of the first-generation Beckman Coulter BioRaptr
instruments that are integrated into our workflow architecture for the preparation of bioassays using 384-
well and 1536-well micro-well plate technology. Although the current BioRaptr dispensers have provided
outstanding service, they are now obsolete having been used for ~17-years (first installed: 2006) and
reached End of Support from the OEM (Beckman Coulter: ~2016); having been maintained by our
internal engineering staff since. However sourcing parts, software upgrades and the obsolete operating
system (Microsoft XP: end of support 2014) are no longer sustainable and compliant with UF IT
informatics security and servicing needs. The UF Scripps HTS center seeks funds to purchase the three
BioRaptr dispenser replacements needed to continue providing full HTS support to our UF Scripps
faculty and the broader NIH research community as a whole. In addition, to provide extended support
for antiviral and infectious disease drug screening (1U19AI171954), a miniaturized version of the
BioRaptr known as the Precise Drop™ II Micro-Dispensing System, which is compatible with biosafety
laminar flow-hood usage, is requested. Plate dispensers are a critical component of HTS screening
campaigns having the task of preparing bioassay titer plates for parallel workflow processing employed
in our HTS screening operations. These units are capable of dispensing a variety of biologicals including
buffers, proteins, detection agents, wash reagents and living cells with high precision and broad 50nL
to 100uL range. Their loss of function would essentially impede the execution of parallel HTS screening
operations needed to meet time-dependent workflow obligations. No other dispensers with 1536w
capabilities are available at the Herbert Wertheim UF Scripps Institute. The UF Scripps HTS center
served as one of four comprehensive HTS centers commissioned by the NIH during the MLPCN
program (2005-2013). In this MLPCN era, we had performed over 280 HTS campaigns using these plate
dispensers. To date well over 400 HTS drug discovery campaigns have been supported through the use
of these dispensers. It is crucial that these devices be replaced in a timely fashion to avoid crippling
ongoing NIH-funded activities and hindering research programs aimed at advancing basic and
translational research. Instrument support from the NIH will help ensure that the UF Scripps HTS
`services can meet its current and future obligations in a timely fashion without interruption to NIH-funded
HTS activities.

Public health relevance
PROJECT NARRATIVE: High Throughput Screening (HTS) employs advanced automation to test very large and diverse compound libraries for finding novel chemical modulators that serve as the basis for early-stage drug discovery. HTS workflow architecture must orchestrate the use of multiple instrumental components (i.e., dispensers, incubators, plate readers…) in concert with one another to complete parallel screens in support of an HTS drug discovery campaign. Requested are replacement dispensers that automate the bulk reagent dispensation into assay plates since the present units are obsolete having reached “End of Support” for equipment hardware and software operating systems.